Development of enthesopathy in the mouse model of X-linked hypophosphatemia

X-linked hypophosphatemia (XLH) is the most common form of inheritable rickets characterized by
mutations in PHEX. These mutations result in elevated serum levels of FGF23, which leads to
hypophosphatemia, rickets, and osteomalacia. FGF23 also inhibits vitamin D 1-a-hydroxylase (Cyp27b1), thus
blocking 1,25 dihydroxyvitamin D (1,25D) production. Pathologic mineralization of the enthesis (tendon-bone
attachment site), referred to as enthesopathy, is a debilitating complication of XLH that causes significant pain
and impaired mobility in affected individuals. Common sites affected include the patellar and Achilles entheses.
The pathogenesis of XLH enthesopathy is poorly understood. We previously demonstrated that Achilles
entheses from mice with XLH (Hyp) have an expansion of hypertrophic appearing cells (HECs) that exhibit an
aberrant chondrogenic phenotype with enhanced BMP/IHH signaling by P14. Treatment of Hyp mice with
1,25D or a FGF23 blocking antibody (FGF23Ab) early in development (P2) similarly prevented enthesopathy
despite the dramatic increase in FGF23 expression in bone, suggesting impaired 1,25D action underlies the
enhanced BMP/IHH signaling observed in Hyp enthesopathy. In both mice and humans with XLH, 1,25D
therapy cannot reverse enthesopathy, supporting the hypothesis that early restoration of 1,25D is needed to
prevent enthesopathy. The increase in serum 1,25D levels wane post-initiation of FGF23Ab in both mice and
humans with XLH, suggesting FGF23Ab may not be effective in preventing enthesopathy in XLH patients.
There is no data on the effects of optimized 1,25D monotherapy or FGF23Ab on enthesopathy in XLH patients.
Therefore, given the similar responses of mice and humans to 1,25D and FGF23Ab, studies on the hormonal
regulation of XLH enthesopathy are essential to guiding future clinical studies on enthesopathy prevention.
Preliminary data show that XLH enthesopathy results from impaired 1,25D action, not actions specific
to FGF23 or consequences of the Hyp mutation. Studies in Aim I will examine mice with global deletions of
Cyp27b1, FGF23, or both with or without the Hyp mutation to address the hypothesis that impaired 1,25D
action leads to enhanced BMP/IHH signaling and enthesopathy. Studies will also elucidate if decreased local
1,25D action leads to enthesopathy. Since our data demonstrates increased BMP signaling is accompanied by
enhanced GDF5 expression in Hyp entheses, studies in Aim II will identify a pathogenic role for GDF5/BMP
signaling in Hyp enthesopathy development. Studies will determine the time course of GDF5 expression in WT
and Hyp entheses. Ablation of GDF5 in Hyp entheses will define the role of GDF5 in the activation of BMP/IHH
signaling in XLH enthesopathy. Inhibition of BMP signaling in Hyp mice will show that IHH signaling is activated
by BMP signaling in entheses and enhanced BMP/IHH signaling directly leads to enthesopathy. Taken
together, these studies will identify novel hormonal and molecular regulators of XLH enthesopathy and normal
enthesis development. They will also identify targets for the design of new therapies to prevent enthesopathy.

Public health relevance
Project Narrative We have previously demonstrated the importance of molecular pathways that control cartilage development in regulating the abnormal mineralization of where tendon attaches to bone (enthesis) seen in the hereditary bone disease called X-linked hypophosphatemia (XLH). These studies will characterize how the interplay of the hormone 1,25 dihydroxyvitamin D, cartilage-regulating molecule Growth Differentiation Factor 5 (GDF5), and cartilage-regulating signaling pathways modulate the development of the abnormal enthesis mineralization observed in XLH. Improved knowledge of the molecular pathways that lead to this abnormal mineralization will allow for identification of therapeutic targets for the treatment of XLH and will also allow for better understanding of the maturation of the tendon-bone attachment site. .